Dopaminergic Modulation of Hippocampal-Cortical Interactions in Learning

PROJECT SUMMARY
The hippocampus plays a critical role in the formation of episodic memories. The current predominant
hypothesis is that memories are gradually established across distributed cortical networks under the influence
of hippocampal activity. Dopamine influences memory processing by signaling the motivational salience of
behaviorally relevant stimuli and by modulating the plasticity of cortical and hippocampal circuits. However, our
understanding of the impact of hippocampal inputs and dopaminergic modulation on cortical circuits during
memory processing remains incomplete. Here we propose to use two-photon imaging to characterize the
evolution of hippocampal inputs, dopamine dynamics, and neuronal responses in the auditory cortex
throughout the formation of associative auditory memories. In addition, we will measure the plasticity of
hippocampal inputs and their modulation by dopamine in vivo. Finally, we propose to use a combination of
optogenetic and pharmacological perturbations of the hippocampal inputs and dopamine levels in the auditory
cortex to determine their functional role in the learning and consolidation of auditory memories. Characterizing
hippocampal-cortical interactions and their neuromodulation is of fundamental importance for understanding
the circuit mechanisms underlying memory formation and can provide the foundation for elucidating how these
mechanisms are perturbed in memory disorders.

Public health relevance
PROJECT NARRATIVE The interactions between hippocampal and cortical circuits play a critical role in the process of memory formation, and dopamine influences memory processing by signaling the motivational salience of stimuli. The proposed project seeks to characterize the circuit mechanisms underlying the modulation of cortical networks by hippocampal inputs and dopamine across learning. A deeper understanding of hippocampal-cortical interactions and their neuromodulation may provide the foundation for identifying circuit elements that are selectively misregulated in memory disorders, such as Alzheimer's disease.